Plans4Care: Personalized Dementia Care On-Demand

PROJECT ABSTRACT
Although >11 million family/friends are caregivers to >6 million people with Alzheimer's Disease (AD) and AD-
Related Dementias (AD/ADRD), they do not typically receive personalized education, strategies and support to
manage their own wellbeing and complex dementia-related symptoms. Lack of personalized care contributes
to $321 billion annually in AD/ADRD care costs. In response, our company, Plans4Care, Inc, proposes a Fast-
Track SBIR (PAS-22-196) to build and test a digital platform that delivers personalized care plans to caregivers
on a smartphone, tablet or computer. To generate a personalized care plan, caregivers select a care challenge
(from >50) they seek to address, and respond to brief, easy-to-answer questions (assessment). A novel clinical
algorithm, developed by Plans4Care, maps the challenge and assessment results to the company’s database
of >1,000 evidence-based strategies. A resultant personalized care plan contains education about the care
challenge and specific strategies modifying the environment, communications, tasks, and/or activities.
Caregivers also have access to trained dementia specialists (care advisors) for one-on-one tele-support as
needed. Phase I will develop and evaluate a prototype. Phase I specific aims include: Aim 1: Develop a
clickable prototype with clinical algorithms that map 5 common care challenges to brief assessments and
evidence-based strategies to generate tailored care plans; and Aim 2: Determine feasibility (able to use
platform to identify challenge/generate care plan), acceptability (appeal, appropriateness), and usability (able
to navigate), using focus group and survey methodologies involving validated measures with 25 diverse
caregivers (racially, ethnically, age, relationship, geography). At the conclusion of Phase I, quantitative
milestones (go-no go) to transition to Phase II are: 1) 25 caregivers enrolled; 2) 75% complete assigned
Plans4Care task: onboard, identify care challenge, generate care plan (feasibility); 3) 75% rate Plans4Care
acceptable; and 4) 75% rate navigation easy-to-use (usability). During Phase II, we will ascertain if embedding
Plans4Care into large geriatric primary care practices (part of accountable care organizations) results in
improved caregiver wellbeing and reduced acute care utilization by people with AD/ADRD, and a commercially
viable product. Phase II specific aims include: Aim 3: Incorporate Phase I feasibility feedback to complete
the build out of the platform to address all 50+ care challenges, and develop our solution into a commercial
product; and Aim 4: Conduct a two-group randomized controlled trial (n=160) to evaluate if Plans4Care
improves diverse caregivers’ wellbeing and reduces acute care utilization of people with dementia. This aim
will formally provide evidence for the platform and its implementation in primary care/ACOs. Our company was
competitively selected to participate in the NIA Healthy Aging Start-Up Bootcamp. The commercialization
potential of an easy-to-use tool providing personalized care that is integrated into ACOs is unique and
desperately needed in the marketplace.

Public health relevance
NARRATIVE In response to the lack of scalable, personalized support for family caregivers of people with Alzheimer’s Disease (AD) and AD related Dementias (AD/ADRD), our company, Plans4Care, Inc, proposes a Fast-Track SBIR to build and test a digital platform that delivers personalized care plans to caregivers on a smartphone, tablet or computer. A novel clinical algorithm links >50 care challenges to >1,000 nonpharmacological strategies to generate a personalized care plan that provides disease education and specific strategies to address care challenges and access to telephone sessions with a care advisor as needed. Standardized measures will assess feasibility, acceptability and utility in Phase I, while a randomized trial with 160 caregivers enrolled through primary care will evaluate its effectiveness to improve caregiver wellbeing and reduce health care utilization of people with AD/ADRD in Phase II.